A kinase-independent role for EGFR in p38MAPK suppression and S-phase progression in head and neck cancer

Head & Neck cancer (HNC) is the sixth most prevalent cancer worldwide, with over 600,000 new diagnoses
annually. Epidermal growth factor receptor (EGFR) is overexpressed in HNC and leads to poor prognosis.
Surprisingly, however, FDA-approved drugs that inhibit canonical EGFR signaling have had limited success in
the clinic, suggesting that disease progression relies on non-canonical mechanisms of EGFR signaling. We have
discovered such a non-canonical mechanism that consists of a hexameric receptor complex organized by
syndecan-4 (Sdc4) containing EGFR, the hepatocyte growth factor receptor homologue MST1R/RON, the
laminin-binding α3β1 and α6β4 integrins, and a second syndecan, Sdc2. RON and the cytoplasmic/nuclear
kinase c-Abl become constitutively activated when incorporated into this complex, suppressing activation of
p38MAPK that would otherwise cause immediate cessation of DNA synthesis and S-phase arrest. A peptide
(SSTNEGFR) that represents the extracellular docking site in Sdc4 competitively blocks the formation and signaling
of this receptor complex. Preliminary findings show that SSTNEGFR prevents the invasion of HNC cells and
induces their rapid cell cycle arrest. Whereas invasion relies on active EGFR, cell cycle progression depends
on EGFR but not its kinase activity, identifying a non-canonical EGFR signaling mechanism that is likely to be a
critical new therapeutic target in cancers such as HNC that overexpress EGFR. Remarkably, SSTNEGFR does
not cause cell cycle arrest in normal oral epithelial cells. Specifically, we plan to: (1) define the molecular
organization and signaling mechanism of the Sdc:RTK:ITG complex, focusing on molecular interactions used by
the two syndecans to assemble this complex, (2) identify the c-Abl and p38MAPK targets that govern stress
signaling and S-phase arrest, and (3) test the efficacy of SSTNEGFR against human HNC patient-derived
xenografts (PDXs) and the 4-NQO mouse model of HNC to determine at what stages in the initiation and
progression HNC the therapeutic is effective. Our goal will be to understand the molecular underpinnings of this
unique receptor complex, understand how it drives HNC and identify it as a possible new target for therapeutics
to treat HN disease.

Public health relevance
EGFR has a causal role in head and neck cancer (HNC), yet therapeutics that target this receptor and its kinase activity have shown only modest clinical benefit, suggesting that EGFR participates in signaling mechanisms that do not require its kinase activity. We identify a novel signaling mechanism organized by syndecan-4 (Sdc4) and Sdc2 that relies on EGFR, but not its kinase activity, to suppress stress signaling in HNC cells and prevent rapid S-phase arrest arising from p38MAPK targeting the replisome engaged in DNA synthesis. Importantly, a promising peptide therapeutic that targets this mechanism causes rapid S-phase arrest in tumor cells or pre- cancerous oral epithelial cells expressing HPV oncogenes, important etiological factors in HPV+ HNC, but not normal oral epithelial cells. This Project will explore the molecular underpinnings of this mechanism in vitro and in vivo, potentially providing new insight into how to combat this cancer.